Substance Misuse and Family Violence Treatment for Fathers

PROJECT SUMMARY / ABSTRACT
The proposed stage II intervention efficacy trail is designed to address two significant co-occurring issues for
fathers with substance use (SU) problems: Intimate partner violence (IPV) and child maltreatment together
defined as family violence (FV). SU treatment programs are an important avenue to reduce family violence
because SU treatment alone does not result in an end to these behaviors. Currently available interventions have
had little success in reducing male FV. Fathers for Change, an integrated outpatient intervention, shows promise
as an intervention model targeting the intersection of SU and FV. The intervention uses men's roles as fathers
as a motivation for change and targets emotional dysregulation as the common factor associated with all three
problems. It is composed of 9 core topics designed to increase motivation and reflective functioning and target
poor emotion regulation followed by 4 co-parent topics and 5 father-child topics for a total of 18 sessions. This
project will test the efficacy of Fathers for Change model in reducing SU and FV compared to a comparable dose
of Individual Drug Counseling post-treatment, 3- and 6-month following treatment for fathers with substance use
disorders seen in either community or VA SU treatment settings. Emotion dysregulation will be examined as the
mechanisms through which Fathers for Change reduces SU and FV. The study will test differential outcomes for
high and low risk clients in preparation for implementation in community settings. If Fathers for Change
demonstrates efficacy in reducing SU and FV simultaneously the intervention can readily be integrated into the
more than 2500 outpatient SU treatment programs nationally. Reductions in SU and FV will have major public
health and criminal justice implications.

Public health relevance
PROJECT NARRATIVE / RELEVANCE Intimate partner violence (IPV) and child maltreatment (CM) commonly co-occur with substance use (SU) and this trifecta of problems represents significant and preventable public health issues impacting millions of families each year in the United States. This randomized trial will provide evidence for the efficacy of an integrated fatherhood focused approach to SU, IPV and CM that can be delivered in outpatient substance use treatment settings. An integrated approach that can reduce SU, IPV and CM in one model that is easily exportable to SU treatment facilities will improve physical and mental health outcomes for fathers, mothers and children.